Development Core

DEVELOPMENT CORE PROJECT SUMMARY
The Development Core will help grow population sciences at UCLA by supporting innovative and ambitious
interdisciplinary population research projects and developing the next generation of population scientists
through new initiatives and modifications of our already successful cluster of activities and services. The
successful continuing activities and services and the new initiatives proposed in the Development Core are
designed to improve the innovation, productivity, and impact of population research across CCPR's four
primary research areas. Several of the new initiatives and modifications proposed here entail a substantial
increase in the mentoring commitment of our senior faculty Fellows.
The Development Core has the following six specific aims: 1) Recruit, retain, and advance productive and
innovative population scientists; 2) Provide seed funding for innovative, interdisciplinary, and collaborative
projects; 3) Provide mentoring and a course release program for junior scientists with innovative projects; 4)
Enhance research communication and exchange of ideas among Fellows and other population scientists; 5)
Support applications for extramural funding, especially among early-career scientists; 6) Facilitate the
dissemination of research to external audiences and accelerate the impact of population research on policy
and society. To invest in CCPR's future, the Development Core prioritizes early-stage investigators for all
services. The Dev Core will provide mentorship, activities, and services to scientists at under-resourced
institutions to enhance community access.